Function and evolution of strains in the gut microbiota

PROJECT SUMMARY
The commensal intestinal bacteria, or microbiota, are intricately involved in human health. The
predominant phyla in adult humans are the Bacteroidota and the Bacillota, the latter being
represented mainly by bacteria from the class Clostridia. Shifts in the relative abundances of
Clostridia are associated with a variety of disease outcomes, though it is unclear if there are
specific Clostridia that largely control disease progression or if there are features shared amongst
multiple lineages that collectively dictate microbiota functions. Our approach examines the genetic
determinants of microbiota function with the hypothesis that a subset of metabolic pathways
influence critical microbiota functions. To support this hypothesis, genomic sequences from
Clostridia isolated by our laboratories were compared to identify non-conserved genes. In one set
of isolates identified as Paraclostridium bifermentans, a commensal bacterium with pathogenic
potential, we observed the disparate presence of genes encoding sorbitol catabolism. Sorbitol
can be diet or host-derived and supports pathogenesis of enteric bacteria. In Aim 1, the
transcriptional regulation of P. bifermentans sorbitol catabolic genes and the effects of sorbitol
utilization on competition with the anaerobic pathogen, Clostridioides difficile, will be elucidated.
Furthermore, analysis of multiple P. bifermentans strains suggests that sorbitol metabolism aids
in niche establishment and ecotype stabilization. How strains of anaerobic, spore-forming
bacteria, which constitute a significant portion of the gut microbiota, evolve to occupy distinct
niches to co-exist in the same host has not been examined. In Aim 2, an evolution model will be
established to highlight the intrinsic and environmental forces that shape P. bifermentans ecotype
abundance. Using sorbitol catabolism in P. bifermentans as a model system, we hypothesize that
gene duplication events, a more common form of mutation compared to better recognized single
nucleotide polymorphisms, will enhance growth and competitiveness against pathogens while
reinforcing strain co-existence. This study is significant because it will uncover metabolic genes
encoded by the gut microbiota that may better predict health outcomes compared to associations
with bacterial species. Additionally, the mechanisms that govern strain evolution, which has only
been studied in aerobic bacteria and eukaryotic yeast, will start to be unraveled for the first time
for an anaerobic, spore-forming bacterium, advancing our understanding of how the gut
microbiota establishes, recovers, and changes. This project aligns with the developmental and
cellular processes branch of NIGMS to elucidate the fundamental factors that control cell
responses and microbiome composition.

Public health relevance
PROJECT NARRATIVE The gut microbiota is intricately linked to human health, though there is limited data explaining mechanistic links between specific microbiota members and health outcomes. This study will provide insight into the genetic determinants of microbiota function for bacteria from the class Clostridia and address how these traits contribute to strain evolution. The proposed research will build on our understanding of how a dynamic gut environment shapes microbiota ecology to combat host susceptibility to infection.